HIV antibodies and NK cell ADCC: nanometer-scale tracking of immune synapse dynamics.

Project Summary/Abstract
Structural studies have established that naturally elicited antibodies can bind to HIV envelope (Env) over a wide
range of epitopes and angles mediated by their Fab arm (i.e. “immune complex geometry”). How this affects
antibody dependent cellular cytotoxicity (ADCC) activity, especially by Natural Killer (NK) cells is unknown. Our
knowledge is limited by a poor understanding of how antibody immune complexes orchestrate antibody receptor
based signaling (specifically for Fc gamma RIIIa, FcγRIIIa). The long-term goal is to acquire a more detailed
understanding of how antibodies recruit Fc mediated cellular activity and to develop novel strategies to engineer
antibodies, drugs, and vaccines that can recruit specific effector functions with maximal potency in vivo. The
objective of this proposal is to determine how immune complex geometry impacts NK cell ADCC against HIV
and IgG receptor spatiotemporal dynamics within the NK cell immune synapse (NKIS). Our central hypothesis
is that antibody geometry will modulate FcγRIIIa interaction and ADCC activity in relation to immune complex
geometry. The rationale for this work is that cutting-edge microscopy observations will provide new insight into
ADCC function with immediate impacts on HIV antibody therapeutic design with applications to a broader range
of human diseases. Our central hypothesis will be tested in three specific aims: 1) Determine how immune
complex geometry influences FcgRIIIa interaction during ADCC; 2) Perform single molecule tracking of FcγRIIIa
within the NKIS during ADCC; 3) Determine nanometer-scale localization of FcγRIIIa and signaling kinases within
the NKIS during ADCC. We will pursue these aims using the innovative technique of MINFLUX nanoscopy,
a super-resolution fluorescence microscopy technique that is capable of 1- to 3-nm spatial resolutions in both
2- and 3-dimensions as well as sub-millisecond tracking of single molecules in live cells. Carefully measured
in vitro ADCC activity and Förster resonance energy transfer (FRET) measurements will also complement
our MINFLUX observations and broaden the interpretation of our results. These studies are significant because
they will establish a molecular basis for antibody effector function, especially in relation to NK cell ADCC, that
could improve therapeutics for HIV. The techniques established in this proposal will also be useful for
interrogating antibody ADCC function for other viral pathogens. The expected outcome of our studies is the
characterization of biophysical principles that alter NK cell ADCC activity as well as the molecular mechanics
that form the basis for such activity. These findings will have an important impact on human health by offering
a rational basis for designing improved antibody therapeutics for HIV, as well as other viruses and diseases,
and will increase our basic understanding of NK cell ADCC.

Public health relevance
Project Narrative Natural Killer (NK) cell-mediated antibody dependent cellular cytotoxicity (ADCC) is correlated with delayed progression of HIV disease, but exactly how antibodies regulate ADCC activity through immune complexes is not well-understood. This project will illuminate how the molecular nature of antibody binding to HIV influences NK cell ADCC activity by utilizing cutting-edge fluorescence microscopy to examine antibody receptors at the synapse between NK cells and their targets. The data from this project will form guiding principles to engineer HIV antibody therapeutics and vaccines aimed at eliciting more potent ADCC activity, with potential long-term applications to other human viruses and diseases.